Interrogating the role of inhibitory interneurons of the nucleus accumbens in social attachment

Project Summary
Social attachment is fundamental to our daily lives and is disrupted in various psychiatric disorders. However,
development of new therapeutic options for enhancing social attachment has been hampered by our imprecise
understanding of the underlying cellular and circuit mechanisms. At the heart of neural circuits underlying
social attachment is the nucleus accumbens (NAc), and recent work by my thesis lab, investigating pair
bonding in monogamous prairie voles, suggests that individual neurons of the NAc encode for partner-
associated social interaction.
In a series of new analyses focused on how populations of neurons encode for pair bonding, I found
that neurons exhibited synchronous activity as a function of pair bond formation. Further analyses suggest that
inhibitory interneurons, which provide a powerful source of inhibition within the NAc, may coordinate this
synchrony between neurons. Thus, the goal of this proposal is to examine precisely how NAc interneurons
encode pair bonds, and to test whether NAc interneurons are necessary for bond-induced neuronal synchrony
and for pair bond formation. This project will leverage cutting-edge methods for both observing and
manipulating NAc interneurons and would provide the first interneuron-specific insights into how the prairie
vole NAc facilitates pair bonding.
Together, the experiments in this proposal will expand our fundamental understanding of how social
attachment is supported at the cellular level within the nucleus accumbens. This work will also provide the
applicant with invaluable training for his future career as a pediatric neurologist focused on translating
foundational knowledge from cellular and circuits neuroscience into novel, highly precise therapies for social
dysfunction.

Public health relevance
Project Narrative The nucleus accumbens is a region of the brain involved in maintaining social attachments to partners, the loss of which are detrimental to mental health. Here, I seek to investigate the role of an understudied, but powerful cell type in the nucleus accumbens – the inhibitory interneuron – in the development of social attachments. This proposal will expand our fundamental understanding of how the brain forms and maintains social attachments, thus paving the way for possible therapies for deficits in social bonding.